Center for Mucosal Immunobiology and Rheumatic Disease Pathogenesis Administrative Core

The Administrative Core will support the 43 members of the University of Colorado (CU) NIAMS P30
Rheumatic Disease Research Resource Center (RDRRC) in all aspects of study implementation,
management, execution, regulatory compliance and reporting. The overall goal of this Administrative Core is to
enhance and expand the research base by providing members a direct line for Center communication,
organized access to Research Resource Core consultation and member discounts, and participation in all of
the Programs outlined in the proposal. Dr. Michael Holers will serve as the Administrative Core Director, and
Dr. Kristi Kuhn will serve the function of Associate Director. The Center Administrator, Ms. Lindsay McBride,
will manage the fiscal aspects, and Ms. Becky Alberti-Powell will serve as the conduit for communication and
outreach. The Enrichment Program will be headed up by Dr. Holers, with a focus throughout on early career
development. As part of this, a Pilot and Feasibility Grants Program will be overseen by Dr. Robert Fuhlbrigge,
Dr. Kristi Kuhn will integrate a Specific Aims and Grants Pre-Submission Review Program into the existing
strong CU CTSA-supported program, and as well a Visiting Professor and Novel Technologies Review Series
will be organized and managed. Dr. Kevin Deane will lead the Social Media and Communications Program. An
innovative Patient Impact Program, including both Biomarker and Therapeutic Development components that
will be integrated with the CU Innovations Center, will be co-directed by Dr. Holers and Dr. Ashley Frazer-Abel.
In addition to ongoing RDRRC support, in 2016 the Dean of the School of Medicine (SOM) funded four $20M
Transformational Research programs modeled on the P30 mechanism to bolster core facilities on the campus.
As a result, a strong infrastructure is in place upon which to build new innovative cores within this RDRRC and
also integrate through pilot funding their utilization with already established cores. The Executive Committee,
consisting of the Center Director and Associate Director, the Research Resource Core leadership and
additional CU faculty members with extensive core activities experience, will continually review, prioritize and
appropriately direct requests for RDRRC Core access. The overall scientific leadership is bolstered by
incorporation of an Advisory Committee of recognized internal CU and external experts chaired by Dr. Joaquin
Espinosa, Executive Director of the Linda Crnic Down Syndrome Center and an internationally recognized
expert in the use of data rich pipeline methods to explore the immune basis for complications of trisomy 21.
With many unique resources focused on the role of the mucosa in the pathogenesis of human disease, the CU
RDRRC will be a national resource, as confirmed by multiple external letters of support. The CU SOM Dean
and Department of Medicine will also provide financial support for pilot grants to enhance the success of this
RDRRC. Overall, the mission of the Administrative Core to promote research in the area of rheumatic disease,
with a special emphasis on early career development and improving disease treatment and prevention.